Endothelial Sphingolipid Synthesis and Tissue Inflammatory Response

Endothelial injury promotes the development of atherosclerosis at the site of disturbed flow.
Sphingosine-1-phosphate (S1P), produced by sphingolipid metabolism, is a secreted lipid mediator that
interacts with G protein-coupled receptors, named S1P1-5. Locally produced and circulating S1P
activate S1P receptors, particularly S1P1 the most abundant in the endothelium, to maintain vascular
homeostasis. Altered sphingolipid metabolism and S1P signaling has been implicated in vascular
disease, including coronary artery diseases (CAD). The current grant led to several advances. First, we
discovered a novel mechanism by which endothelial sphingolipid biosynthesis is regulated. Nogo-B, a
membrane protein of the ER, highly expressed in blood vessels, binds to and inhibits serine
palmitoyltransferase (SPT), the rate-limiting enzyme of the de novo sphingolipid production. Second,
we revealed that Nogo-B/SPT interaction downregulates local S1P signaling contributing to
inflammation, hypertension and heart failure. Third, we found that inflammatory stimuli and ox-LDL
induce Nogo-B phosphorylation, which further inhibits SPT activity contributing to endothelial injury.
Fourth, following TNF-α, the N-terminus of Nogo-B is cleaved and translocates to the nucleus to impact
endothelial transcriptome. Our long-term goal is to understand how Nogo-B regulates local sphingolipid
signaling and its impact on coronary functions in the pathogenesis of CAD. Our hypothesis is that
Nogo-B controls endothelial-derived S1P signaling, which is a key regulator of vascular homeostasis
and disease- thereby influencing coronary plaque progression. Mechanistically, we hypothesize that
Nogo-B promotes vascular inflammation and diseases via two major mechanisms; SPT inhibition, thus
disrupting locally-derived S1P signaling, and the activation of gene profile. The rational is that the
discovery of new mechanisms regulating endothelial inflammation will provide potential therapeutic
targets for CAD. For the renewal, we propose to: 1) Investigate the role of endothelial Nogo-B in the
susceptibility of mice to coronary atherosclerosis; 2) Determine the importance of endothelial S1P
signaling and its role as downstream effector of Nogo-B in the onset of coronary atherosclerosis; 3)
Dissecting the mechanism of Nogo-B signaling in myocardial endothelial injury.
This contribution is significant since will identify novel targets for the treatment of CAD, especially since
available therapies have been only partially successful, and beyond the statins, there are currently no
effective pharmacological strategies that effectively address vascular inflammation. The proposed
research is innovative because we investigate the effects of altered sphingolipid homeostasis and S1P
signaling on the progression of coronary atherosclerosis, by using a novel mouse model of CAD and
myocardial infarction that better recapitulates the human disease, a heretofore-unexamined process.

Public health relevance
Project Narrative The proposed research is relevant to the public health because CAD remains a top determinant of mortality, and represents a major economic burden based on 2017 report of AHA. From this study, we will understand the role for Nogo-B-dependent sphingolipid metabolism and S1P signaling in atherosclerosis, and this finding will provide a framework for target and drug discovery directed to ameliorate vascular inflammation in CAD and other CV conditions.